Isocitrate dehydrogenase (IDH) mutations as drivers of organelle stress and dysfunction"

ABSTRACT/SUMMARY
The consequences of mutations in isocitrate dehydrogenase 1 (IDH1) and IDH2 in cancer are unusual. Though
these mutations confer a loss of function of the normal activity of the NADP+-dependent conversion of isocitrate
to α-ketoglutarate (αKG), mutant IDH is more of an oncogene than tumor suppressor, as a neomorphic activity
is also conferred: the NADPH-dependent production of oncometabolite D-2-hydroxyglutarate (D2HG) from αKG.
D2HG inhibits αKG-dependent enzymes like DNA and histone demethylases, and NADPH depletion results in
oxidative stress. A variety of point mutations affecting residue R132 in IDH1 can grant these catalytic properties,
causing prominent structural modifications that allow mutant IDH1 to be a bona fide drug target. Indeed, a se-
lective allosteric mutant IDH1 inhibitor is now in the clinic. Both mutant and WT IDH1 localize to the cytosol and
peroxisomes, while IDH2 is found in the mitochondria, raising the possibility of organelle-specific consequences
of IDH mutations, though this has not yet been explored. Interestingly, there is a communication pipeline between
the peroxisomes and mitochondria in that they share an interconnected role in lipid processing and mitigation of
oxidative stress, though the role of IDH in this communication is not yet known. To date, several limitations have
restricted the rigor of mutant IDH studies. First, the catalytic and inhibition profile for R132H IDH1 is extrapolated
to other disease-relevant IDH1 mutants, though we show several mutants have very unique profiles. Second,
the role of NADPH depletion, and thus oxidative stress, is often overlooked in favor of studying consequences
of D2HG. Third, studies focus on the global/cytosolic contributions of mutant IDH1, ignoring its role of sole
NADPH and αKG producer in this organelle. However, we report evidence of dysfunctional lipid biosynthetic
pathways in the peroxisomes upon introduction of cellular IDH1 mutations. The overall goal of our research
program is to determine the mechanisms of metabolic enzyme catalysis, regulation, inhibition, and cellular/orga-
nellular function in health and disease, from the chemical to the cellular levels. By leveraging kinetic, structural,
cellular, and -omics technologies, we can establish the unique consequences of disease-relevant mutational
variants in metabolic enzymes. Here, we have identified critical questions to illuminate the role of mutant IDH1
in disease: 1) How do protein dynamics affect IDH1 catalysis and inhibition? 2) What are the effects of oxidative
stress on IDH1 and IDH2? 3) What are the organelle-specific consequences of IDH1 mutations? 4) What are the
roles of IDH1 mutations in organelle crosstalk? Through this work, we will uncover fundamental catalytic and
regulatory strategies affecting WT and mutant IDH activity, determine the role of IDH1 in the peroxisomes and
identify the unique consequences of mutation at this location, and establish the role of mutant IDH1 in facilitating
peroxisomal/mitochondrial lipid biosynthesis and oxidative stress signalling. Upon completing this work we will
generate valuable new tools, and identify pathways or mechansims that may be therapeutically targetable.

Public health relevance
PROJECT NARRATIVE Mutations in isocitrate dehydrogenase (IDH) affect patients with gliomas, chondrosarcomas, and acute myeloid leukemia, but the mechanistic consequences of these mutations are still being explored. We propose to leverage our recent discoveries on IDH to elucidate the molecular, trans-organellular, and cellular mechanisms of dysfunction. This work is expected to establish the fundamental features of IDH mutations, ultimately providing tools for predicting patient prognosis and illuminating new disease-driving pathways.